Developing Lithium as a Disease-Modifying Therapy for Emphysema Using a Precision Medicine Approach

PROJECT SUMMARY/ABSTRACT
Chronic Obstructive Pulmonary Disease (COPD) is the fourth leading cause of death among adults in
the United States; nonetheless, we lack disease-modifying therapies. Herein, we hypothesize that lithium may
be a novel disease-modifying agent for emphysema in smokers.
Lithium is an abundant naturally occurring element that is ubiquitous in soil and groundwater from where
it enters our food chain and drinking water supply. Once ingested, lithium is distributed across total body water
as it diffuses freely across cell membranes. Lithium can be quite toxic when used in the high doses needed to
treat mood disorders. In contrast, natural low-level lithium intake from food and water is associated with multiple
beneficial effects, including a lower risk of suicide, depression, Parkinson’s and Alzheimer’s diseases, and
improved longevity in independent studies. Therefore, low-dose lithium supplements are available over the
counter in the US. Lithium exerts biological effects by activating WNT/β-catenin signaling, which is essential for
lung development and to repair damaged alveoli, such as those observed in smokers with emphysema.
Our preliminary work suggests that lithium may be a novel protective agent against emphysema. These
preliminary findings are based on data from animal models, human patient-derived precision-cut lung slices,
users of lithium medication in independent cohorts, assessment of circulating lithium levels in nonusers of lithium
medication, and analysis of environmental lithium exposure using independent environmental datasets.
During this award, we will assess circulating lithium levels in smokers enrolled in two COPD research
cohorts and determine if they are associated with emphysema progression, use extensive proteomic and
genomic data from both cohorts to identify the subset of smokers most likely to experience less emphysema
progression by augmenting circulating lithium levels, and assess the dose-response relationship between lithium
and WNT/β-catenin activity in explanted COPD lung tissues.
Our overall objective is to advance lithium from ex vivo and observational human studies to clinical trials
as a novel disease-modifying agent for emphysema by substantiating efficacy, implementing precision medicine,
and defining a dosing strategy.

Public health relevance
PROJECT NARRATIVE This proposal seeks to generate new knowledge regarding the pathogenesis and treatment of Chronic Obstructive Pulmonary Disease, the fourth leading cause of death in the US. Specifically, we propose to investigate how a naturally occurring element in the environment, i.e., lithium, may prevent the progression of COPD in smokers, identify the subset of smokers likely to benefit from lithium treatment, and determine the optimal dose of lithium that may protect against COPD. Our overall objective is to develop lithium as a novel treatment that can modify the natural course of COPD.